Transcription factors mediate postnatal neurogenesis from enteric glial cells

PROJECT SUMMARY
The enteric nervous system (ENS) plays a vital role in gastrointestinal biology by regulating gut motility,
secretion, and absorption, and by interacting with the immune system. Dysregulation of the ENS thus
contributes to many diseases, including the inflammatory bowel diseases (IBDs) ulcerative colitis (UC) and
Crohn’s disease (CD). IBDs are associated with increased density of enteric neurons and activation of enteric
glial cells, and existing evidence suggests that these effects directly contribute to the pathobiology of IBDs.
Understanding the role of ENS components in UC and CD is thus critical for developing targeted therapies.
Recent papers both from our group and from other laboratories have demonstrated that some ENS glial cells
switch fates to become neurons in response to inflammation. The ENS glia thus contain a subset of neuronal
progenitor cells, and inflammatory signals trigger this population to generate new neurons. However, it is not
clear how glial cells alter their transcriptional program to generate neurons, and what subgroups of glia are
involved in this process is unknown. The goal of this project is to test the hypothesis that specific transcription
factors with known roles in prenatal neurogenesis induce postnatal neurogenesis in the ENS in response to
inflammation. Phox2b is a transcription factor with critical roles in both ENS and central nervous system
neurogenesis, and preliminary data shows that it induces cultured glia to adopt a neuronal phenotype. I
hypothesize that colonic inflammation will trigger Phox2b-mediated neuronal fate acquisition in a subset of
enteric glial cells. To test this hypothesis, I will use single cell RNA sequencing and a conditional Phox2b
knockout mouse model. Completion of this project will significantly enhance our understanding of enteric glia in
the pathophysiology of IBDs, and will reveal molecular pathways that may represent therapeutic targets. This
work will also reveal glial subpopulations with potential to be harnessed therapeutically to regenerate missing
neurons. In addition to the proposed research, this fellowship will provide training to plan, execute, and analyze
data from experiments utilizing RNA sequencing techniques, to breed mice to generate tissue-specific
conditional knockout models, to culture and manipulate primary enteric glial cells, to effectively communicate
scientific data in writing and orally, and to manage and lead a scientific project. Upon completion of the
fellowship, I will be prepared to launch my own career as an independent, NIH-funded scientist studying
gastrointestinal biology.

Public health relevance
PROJECT NARRATIVE This project seeks to understand how enteric glial cells alter their transcriptional program to generate neurons in the postnatal gastrointestinal tract. It is known that some glial cells react to inflammatory signals by transitioning to a neuronal fate, but the molecular factors that drive this process are unknown. I will utilize single cell RNA sequencing and conditional knockout mouse models to test the hypothesis that the developmentally-important transcription factor Phox2b mediates postnatal neurogenesis from a subset of enteric glial cells.